Training in Clinical Translational Science: Maximizing the Public Health Impact

Project Summary/Abstract
This program is focused on leveraging two innovative developments in medicine and clinical science to
enhance the predoctoral training of psychological and brain scientists to make breakthroughs in understanding,
preventing, and treating severe psychopathology. One development, the NIH initiative to foster clinical
translational science (CTS), is motivated by the unmet critical need to move clinically-relevant scientific
discoveries along the translational pipeline–from basic science to controlled research with clinical populations
to dissemination and implementation–in order to make a substantive public mental health impact. A second
development, the NIMH Research Domain Criteria (RDoC) initiative, is motivated by the critical need to
develop multi-dimensional, multi-unit of analysis approaches to understanding psychopathology. Advances in
clinical psychological science will come from a new generation of investigators with expertise at the
intersection of these two NIH-driven developments. The ultimate goal of this training program is to maximize
the likelihood of producing independent clinical research scientists and leaders with expertise in cutting-edge
translational research designs, frameworks, and methodologies that will usher in breakthroughs in the
identification of mental illness mechanisms, prevention, and treatment. Following a successful initial training
period (years 1–4; 13 trainees), federal funds are requested to continue supporting six predoctoral trainees per
year, along with two new institutionally supported trainees, for up to two years. Training opportunities center
around four basic aims for each trainee: (1) to gain exposure to foundational concepts, theories, and
methodologies, as well as exemplars of both CTS and multiple units of analysis informed by the RDoC; (2)
apply this integrated framework to research addressing a public health issue; (3) to learn to foster collaborative
opportunities that stretch the boundaries of research both along the CTS continuum and across multiple units
of analysis; and, (4) develop professionally to continue this line of research as an independent clinical scientist.
Trainees begin their intensive training by identifying a public health issue on which to focus their research
efforts. These aims are then realized through: (a) structured research activities under the dual mentorship of a
primary and a “stretch” mentor (designed to extend the research either along the CTS continuum or across a
unit of analysis); (b) dual research mentoring of the trainee leading to submission of an NRSA application; (c)
peer, advanced trainee, and expert guidance and feedback on their research through participation in a year-
long seminar; (d) tailored doctoral qualifying examinations; (e) coursework and advanced seminars focused on
addressing mental health issues within the CTS and RDoC frameworks; (f) workshops in professional
development, responsible conduct of research, and grant writing; and (g) colloquia series and conference
attendance to encourage networking and collaborative opportunities. Trainees work with their dual mentors to
design an individualized program of study in combination with the activities listed above.

Public health relevance
Project Narrative This program will provide innovative and comprehensive predoctoral research training at the intersection of clinical translational science and the Research Domain Criteria using a dual mentorship model. Six NIH and two institutionally-funded psychological and brain science trainees per year will receive structured applied experiences, didactics, seminars, and workshops from both core and “stretch” faculty with a specific focus on the development of a clinical translational program of research, grant writing, and professional development.